Project 2: Racial/ethnic differences, impact on tumor microenvironment and mortality

Project Summary/Abstract of Project 2
Colorectal cancer (CRC) incidence and mortality vary substantially by race/ethnicity in the United States (US).
Alaska Natives have among the highest reported rates of CRC in the world; African Americans also shoulder
an elevated burden from this disease compared to other groups within the US. In exploring factors that may
contribute to these observed disparities, minimal consideration has been paid to the potential contribution of
the microbiome. Although the presence of a gut microbial community is common across all human populations,
the composition of that community varies greatly – by sex, diet, and race/ethnicity. The composition of the gut
microbiome has plausible implications for a variety of pertinent health outcomes, including CRC. Increasing
evidence indicates that specific gut bacteria, or imbalances in bacterial populations, could play a role in the
natural history of CRC. For example, Fusobacterium nucleatum has been suggested to infiltrate the colorectal
epithelium, promote CRC by increasing oncogene expression and inflammation, and contribute to poorer CRC
survival. However, many questions remain as to the contributions of the microbiome to CRC across population
groups, and the implications of those contributions. The objective of this study is to identify differences in the
tumor-associated microbiome in CRC by race/ethnicity, associations of the tumor-associated microbiome with
other aspects of the tumor microenvironment, and the impact on CRC survival. In Aim 1, we will assess
differences in the bacterial community in CRC by race/ethnicity, focusing on both suspected candidate bacteria
with plausible roles in CRC pathways (i.e., F. nucleatum, enterotoxigenic Bacteroides fragilis, and polyketide
synthase-positive Escherichia coli – Aim 1a) and agnostic community-wide assays (Aim 1b). In Aim 2, we will
examine how our evaluated candidate bacteria (2a) and agnostic patterns of bacterial community structure (2b)
relate to prognostically-relevant gene-expression-based CRC subtypes and immune profiles in CRC tissue,
considering possible differences by race/ethnicity. Lastly, in Aim 3, we will evaluate the relationship of
suspected candidate bacteria (3a) and agnostic patterns of bacterial community structure (3b) with CRC
survival, again considering possible differences in associations by race/ethnicity. In pursuit of these Aims, we
will conduct targeted candidate (e.g., F. nucleatum-specific) and agnostic global assays (i.e., 16S rRNA gene
sequencing) to characterize the bacterial community in CRC for 840 CRC cases from existing study resources
with coverage of four racial/ethnic groups: Alaska Native people (n=210), African Americans (n=210),
Hispanics (n=210), and non-Hispanic whites (n=210). Generating and contrasting information on the tumor-
associated microbiome across racially/ethnically diverse groups, and relating all these data to CRC outcomes
will provide an opportunity to advance our understanding of the microbiota’s role(s) in CRC health disparities.
Information gained from this project will inform future strategies for targeted interventions and CRC control with
the goal of reducing observed disparities in CRC incidence and mortality.

Public health relevance
Project Narrative of Project 2 The bacterial community of the human gut varies across population groups and plays a role in the development and progression of colorectal cancer. In this project, we will characterize the bacterial community in colorectal cancers, evaluate how that community differs by race/ethnicity, and assess its impact on tumor biology and survival. Information gained from this project will inform future strategies for targeted interventions with the goal of reducing observed disparities in colorectal cancer.